Motor cortical control of dopamine release dynamics during motor learning

PROJECT SUMMARY
Motor skill learning, which requires knowledge of body position and real-time feedback of performance, is
essential for survival and quality of life. In addition to experiencing general motor deficits due to the loss of
dopamine neurons, Parkinson’s patients also experience disruption in motor learning. Dopamine signaling from
the substantia nigra pars compacta (SNc) to the dorsal striatum plays a crucial role in mediating motor learning
as ablation of dopamine neurons in this pathway renders mice incapable of learning a motor skill task while
minimally affecting general locomotion. SNc dopamine neurons that project to the DLS receive various excitatory
and inhibitory inputs that can modulate its neuronal activity and its downstream dopamine release. Anatomical
studies have shown that the motor cortex (M1/2) directly synapses onto DLS-projecting SNc dopamine neurons,
however its functional role remains unknown. In Aim 1 and 2 of this proposal, I will test the hypothesis that M1/2
inputs onto DLS-projecting SNc dopamine neurons undergo synaptic plasticity during motor learning and is able
to modulate dopamine release in vivo during motor learning. Although dopamine signaling is required for the
acquisition of motor skills, the specific pattern and progression of the dopamine signal over the course of motor
learning and how it leads to motor learning impairments remain unclear. In Aim 3, I will link dopamine release
dynamics in the dorsolateral striatum (DLS), an area that’s been implicated motor learning and habitual
behaviors, to specific kinematics and behavioral features across motor learning using an accelerating rotarod.
Findings from these proposed studies will shed light on the neural mechanisms of motor cortical control of motor
learning and will have broader implications in movement disorders like Parkinson’s Disease.

Public health relevance
PROJECT NARRATIVE Motor skill learning, which is essential for the survival and quality of life, is disrupted in Parkinson’s patients and is known to require dopamine signaling. This proposal aims to examine the motor cortical control of dopamine release that supports motor learning and to link specific striatal dopamine release dynamics to kinematics and behavioral features during motor learning. Understanding the neural mechanisms of motor learning will have broader implications in motor disorders like Parkinson’s Disease.